Discovery and Characterization of Novel Halogenases from the Human Microbiome

PROJECT SUMMARY/ABSTRACT Flavin-dependent halogenases (FDHs) are biosynthetic enzymes from bacteria and fungi that catalyze regioselective C-X bond formation (X=Cl, Br, I) with various aromatic substrates. Their regioselectivity and environmentally friendly reaction conditions make FDHs attractive candidates for green synthesis of aryl halides to be used in transition metal catalyzed cross- coupling reactions. The proposed project will expand our understanding of regioselective aryl halide formation by FDHs through the identification and structural and enzymatic characterization of novel members of this family of enzymes, expanding the FDH toolkit by adding new members with different substrate and halide selectivities to the currently characterized enzymes. In Aim 1 of this project, we will fully characterize the extended substrate scope of AbeH and BorH, two FDHs from soil bacteria metagenomes that we have shown can chlorinate and brominate tryptophan to produce two different regioisomers. Aims 2 and 3 are based on our hypothesis that FDHs are also produced by the bacteria of the human microbiome, where they could potentially generate secondary metabolites that play a role in chemical communication between bacteria and human cells. This hypothesis is supported by the fact that a simple bioinformatic search of three sequence files from human microbiome metagenome shotgun sequencing projects yielded five ORFs predicted to encode novel FDHs. Preliminary investigations of the first of the five hypothetical FDH genes has verified that it encodes a protein with the ability to halogenate indole. Aim 2 will involve the full characterization of the enzymatic activity, substrate and halide scope, and crystal structures of these five putative microbiome FDHs. Aim 3 will establish a training program in bioinformatics, enzymology, and structural biology for undergraduate biochemistry majors, who will mine human microbiome metagenome sequences for additional putative FDH genes, express and purify the gene products in E. coli, and characterize their structures and activities.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT/PROJECT NARRATIVE This project will identify and characterize new flavin-dependent halogenase enzymes produced by the bacteria of the human microbiome, the unique community of microorganisms that inhabit our gut, skin, and other tissues and contribute to human metabolism, immunity, and brain function. Flavin-dependent halogenases catalyze regioselective chlorination, bromination, or iodination of aromatic compounds and we are interested in identifying novel members of this family in order to improve their potential to be used as biocatalysts for an environmentally friendly green chemistry approach to synthesis of aryl halides, key building blocks for pharmaceuticals that treat a wide variety of conditions, as well as agrochemicals and other commercially important molecules. Characterization of these enzymes will also provide new insights about some of the molecules that are synthesized by our microbiome and how our cells and the bacterial cells that colonize our body use chemistry to communicate with one another.